BD FACSDiscover S8 Image-Enabled Spectral Cell Sorter

PROJECT SUMMARY/ABSTRACT
Funding is requested for the Becton Dickinson FACSDiscover S8, a high-end next-generation cell sorter with
unprecedented capabilities. The FACSDiscover S8 combines traditional high-speed electrostatic droplet
deflection technology with three novel features: real-time imaging, full-spectrum detection, and 6-way sorting.
With these unique capabilities, the FACSDiscover S8 can identify and purify up to 6 unique cell populations
based on morphology, spatial resolution of fluorescence signal, and spectrally unmixed fluorescence signals for
high-parameter measurements and subtraction of autofluorescence background for increased sensitivity. The
integration of the FACSDiscover S8 in the established and highly utilized Columbia Stem Cell Initiative (CSCI)
Flow Cytometry Core Facility at Columbia University Irving Medical Center (CUIMC) will provide Users across
the entire Columbia University campuses broad access to a currently unavailable technology that will vastly
expand the analytical capabilities and research opportunities of our scientific and medical community. The
FACSDiscover S8 will facilitate identification of unique cell populations with intricate granularity and will generate
deep insights into a broad array of human diseases investigated by the world-renowned researchers at Columbia
University, including in research areas such as stem cells, aging, neurodegeneration, cancer biology,
immunology, and bioengineering. The FACSDiscover S8 will therefore address an urgent and unmeet for our
Users and, given its cutting-edge technology, will also be a powerhouse for new discoveries for many years to
come.

Public health relevance
PROJECT NARRATIVE The FACSDiscover S8 Image-Enabled Spectral Cell Sorter is a powerful, cutting-edge research instrument capable of identifying dozens of unique cell populations from biological samples using fluorescence and imaging measurements. These cell populations can then be isolated with extremely high purity and subsequently analyzed to provide a deeper and much needed understanding of a wide array of human diseases to help develop the treatments of tomorrow. Allowing such discoveries is the current roadblock addressed by this application, which is aimed at bringing a currently unavailable novel high-end technology at Columbia University for the betterment of human health.